Longevity, Equity, and Aging Research Network (L.E.A.R.N.) Consortium Analysis Core

PROJECT SUMMARY—ANALYSIS CORE
The overall goal of the Analyses Core (AnC) of the of the Longevity, Equity, and Aging Research Network
(L.E.A.R.N) Consortium is to provide biostatistical, epidemiological, and methodological training, mentoring and
assistance, and to guide junior investigators from diverse and underrepresented groups (collectively called
RCMAR Scientists) in the conduct of transdisciplinary ethnogeriatrics health disparities research that
integrates biological, social, behavioral, and cultural considerations. We will train them to use various
innovative techniques, including emerging methodologies (i.e., biomedical data science, digital health methods,
precision medicine techniques and virtual reality and simulation-based interventions), qualitative research,
mixed methods research, and implementation science. The AnC will review, monitor, and provide guidance
and continuing biostatistical, bioinformatics and database support for all our RCMAR Scientists. We will closely
collaborate within our center with the Leadership and Administration Core and the Research Education
Component to provide continuing individualized consulting, training, and education for RCMAR Scientists. We
will also collaborate and share resources with the L.E.A.R.N Consortium faculty, the RCMAR Coordinating
Center and our sister RCMAR centers across the nation. The strength of our core lies in our experienced core
investigators with complementary expertise/experience and exceptional devotion to mentoring and education
of early career researchers. Along with mentoring and consulting, the AnC will provide formal education
through statistics and methods classes in the Stanford Psychiatry Department. The AnC and the Research
Education Component will work closely to direct RCMAR Scientists to the appropriate courses based on the
needs of their pilot projects and their personalized training plan. The AnC will also assist the RCMAR Scientists
with safe and high-quality database management for the pilot projects. As the RCMAR Scientists are early
career researchers, special care will be taken to ensure that, regardless of the nature of pilot projects, they will
be mentored to exercise great caution in handling the human subject data, which will also provide a crucial
opportunity for them to train with and learn from experts on proper management of human subject data. In
addition to supporting RCMAR Scientists, the AnC will actively develop cutting edge statistical and research
methods with the common goal of advancing care of and research on older adults from diverse backgrounds.
Taking advantage of the interdisciplinary forum that will be naturally formed under the proposed RCMAR
program, the AnC will lead and encourage project investigators to collaborate on various statistical and
methodological research topics pertinent to ethnogeriatrics, such as biomedical data science approaches,
bioinformatics, digital health, virtual reality and simulation study design, personalized (precision) medicine,
qualitative and mixed methods, comparative effectiveness, behavioral interventions, effect heterogeneity, and
joint utilization of multiple analytical traditions to effectively handle multitude of information.